Development and Validation of a PBPK/PD Modeling Strategy for Ophthalmic Drug Products to Support Translation from Preclinical Species to Human

Ocular PBPK/PD Model Extrapolation from Animal to Human – Abstract
The Office of Generic Drugs (OGD) is tasked, among other things, with reviewing sponsor applications for
ocular dosage forms that purport to be bioequivalent to the approved formulations for the same drug.
Sponsor companies want to have high confidence that applications they submit for locally acting dosage
forms thought to be bioequivalent (BE) will receive favorable reviews. Software that embodies
physiologically-based pharmacokinetics (PBPK) / pharmacodynamics (PD) modeling can serve as a useful
alternative to conventional BE approaches to evaluate the likelihood that a new locally acting formulation
will be BE to an approved dosage form in the target patient population.
Developing a state-of-the-art capability for ocular PBPK/PD software and defining strategies for
interspecies translation of models requires an extensive knowledge base to serve as the scientific
foundation. Talented scientists apply the knowledge base in the development of useful equations and logic
suitable for software, high-level computer programming skills to encode the equations and logic into user-
friendly software, and other experienced scientists to test, validate, document, and support the software for
the desired application by others not involved in its development.
The goal of this project is to develop and validate a PBPK/PD modeling strategy for ophthalmic drug
products to support translation from preclinical species to human. This will be achieved through a
combination of an exhaustive review expanding the knowledge base of preclinical and clinical PK/PD data
sets and legacy models for ophthalmic products, developing mechanistic PBPK/PD models in preclinical
species in the Ocular Compartmental Absorption and Transit™ (OCAT™) model within the GastroPlus®
software program and extrapolating to human PBPK/PD models, and validating and documenting the
resulting software for use by others. By basing the analyses on the well-established and validated OCAT™
model, which has been funded previously by the FDA and is utilized by both pharmaceutical and generic
drug companies today, we will be able to focus project resources entirely on identifying knowledge gaps
and new strategies to support interspecies translation for ocular drug delivery and establishing scientific
and regulatory standards for supporting innovative development and performing bioequivalence
assessments, rather than having to develop new code for the core program and its many support
capabilities (e.g., integration, plotting, Parameter Sensitivity Analysis, Virtual BE Trial Simulations).
Throughout the effort, we will maintain close contact with the FDA program manager and the Consortium
for Ocular PBPK/PD Model Extrapolation that we propose to form with our collaboration partners and the
FDA to ensure the team focuses on data compilation and model development activities that will result in
successful completion of the specific aims within the scope of the project.

Public health relevance
Ocular PBPK/PD Model Extrapolation from Animal to Human – Project Narrative The goal of this project is to develop and validate a physiologically-based pharmacokinetic (PBPK) / pharmacodynamic (PD) modeling strategy for ophthalmic drug products to support translation from preclinical species to human. This will be achieved through an exhaustive review expanding the knowledge base of preclinical and clinical Pharmacokinetic (PK)/PD data sets and legacy models for ophthalmic products, as well as developing mechanistic PBPK/PD models in preclinical species in the Ocular Compartmental Absorption and Transit™ (OCAT™) model within the GastroPlus® software program and extrapolating to human PBPK/PD models. The findings from this project will help identify knowledge gaps and new strategies to support interspecies translation for ocular drug delivery and establish scientific and regulatory standards for supporting innovative development and performing bioequivalence assessments.